Immune biomarkers to predict outcomes in solid organ transplant patients with bloodstream infections

Project Summary
Solid organ transplant (SOT) recipients are a growing population of immunocompromised patients at increased
risk for infection. Bacterial bloodstream infections (BSI) are common, affecting approximately 26% of SOT
recipients after transplant. Mortality from BSI can reach up to 50% in SOT patients when accompanied with
septic shock. The host immune response is believed to play a pivotal role in determining clinical outcomes from
an infection in a SOT recipient, the details of which are poorly understood. Identifying immunologic biosignatures
that portend prognostic information will lend biological insight into the mechanisms of maladaptive immune
responses to BSI. I will use existing biological specimens from SOT recipients with BSI to test my overarching
hypothesis that serum levels of cytokines, chemokines, immunoglobulin (IG), and differential gene expression
profiles are associated with clinical severity of infection in SOT patients with bacterial BSI. The Specific Aims
of this proposal are: Aim 1: Identify cytokine, chemokine, and IG biomarkers of septic shock and 30-day mortality
among SOT recipients with BSI. Aim 2: Determine differential gene expression profiles and genetic pathways
associated with septic shock and 30-day mortality in SOT patients with BSI. Aim 3A: Use immunologic
biosignatures to develop a prognostic model for SOT patients with BSI. Aim 3B: Externally validate and refine
the prognostic model using samples I will prospectively collect from SOT patients with BSI at Emory Transplant
Center. I expect that completion of these Aims and related training will lead to a better understanding of how the
host immune response influences outcomes in SOT patients during BSI. This information will directly inform
future studies aimed at evaluating immunomodulatory treatment strategies to optimize outcomes of SOT patients
with BSI. My long-term career goal is to become an independent physician scientist leading a team dedicated
to improving outcomes in SOT recipients with bacterial infections. To facilitate my success in completing the
Specific Aims, proposed training, and transition to a new institution, I have assembled an experienced team of
mentors and advisors dedicated to training the next generation of physician scientists. Emory University School
of Medicine is an ideal research environment for my proposal and training. As home to one of the nation’s top
transplant centers, Emory is a highly collaborative research environment equipped with rich resources and
national leaders in biomedical research. Therefore, I will be well positioned for success in developing the
expertise and preliminary data necessary to compete for an NIH R01.

Public health relevance
Project Narrative Bacterial bloodstream infections (BSI) are among the most common and serious infections in solid organ transplant (SOT) recipients. Optimal immunosuppression management in SOT recipients with BSI is unknown but critical to improving outcomes. The proposed studies will identify cytokine, chemokine, immunoglobulin, and gene expression biomarkers of 30-day mortality and septic shock among SOT patients with BSI, enabling the development of an immunologic prognostic model.